MOTIVATE to Improve Outcomes for Older Veterans with Musculoskeletal Pain and Depression

Background: Musculoskeletal (MSK) pain is the leading cause of disability and reduced quality of life among
older adults. We also know that depressive symptoms frequently co-exist with MSK pain and complicate
management. Despite rising costs attributed to MSK pain and depressive symptoms, few behavioral
interventions have been developed to address these comorbid conditions in this vulnerable aging population.
Significance: The PI, during her VA HSR&D CDA2, developed and tested the feasibility of a novel behavioral
intervention targeting older Veterans with chronic back pain and depressive symptoms. MOTIVATE (Moving to
Improve Pain and Depression in Older Veterans) incorporates evidence-based components of motivational
interviewing (MI), values elicitation, goal setting and patient activation to motivate older Veterans to become
more physically active, thereby improving pain interference, function, and depressive symptoms. MOTIVATE is
delivered by a health coach via telephone or video during eight sessions over 12-weeks. Preliminary findings
from the PI’s ongoing pilot trial of MOTIVATE show it is feasible, improves step counts, pain interference, and
depressive symptoms. In response to VA HSR&D research priority areas, this application focuses on improving
access to care, augmenting resources for primary care practices – specifically in the areas of pain
management and aging, and leveraging virtual care to deliver behavioral interventions to vulnerable Veterans.
Innovation/Impact: This research is innovative because we 1) target both MSK pain and depressive
symptoms and enhance generalizability of our findings, 2) incorporate older Veterans’ motivation to change as
a key behavioral determinant, 3) use remote delivery to enhance reach of both pain and mental health services
to older Veterans; and 4) involved older Veterans and other stakeholders at every stage of development.
Specific Aims: We propose a hybrid type 1 implementation-effectiveness randomized controlled trial at two
large VA sites to establish the effectiveness and scalability of MOTIVATE. The overall goals of this study are to
1) examine the effectiveness of MOTIVATE compared to a waitlist control arm on clinical and behavioral
outcomes; 2) explore implementation processes for the MOTIVATE intervention, and 3) evaluate preliminary
cost with a budget impact analysis for MOTIVATE in older Veterans with chronic MSK pain and depressive
symptoms. We hypothesize that MOTIVATE will improve clinical and behavioral outcomes in this population.
Methodology: We will recruit older Veterans with MSK pain and depressive symptoms (n=264) to determine
effectiveness of MOTIVATE versus waitlist control arm to improve clinical and behavioral outcomes at 3
(primary endpoint) and 6 months post-enrollment. The primary outcome is pain interference (a subscale of the
Brief Pain Inventory) and secondary outcomes include depressive symptoms (PHQ-9), pain intensity, arthritis
self-efficacy, pain catastrophizing Scale, PROMIS scales (including sleep), resilience, frailty, and Global
Impression of Change. Using intent-to treat analyses, we will compare MOTIVATE and waitlist groups in terms
of primary and secondary outcomes by using a linear mixed-effects model which simultaneously models all
available measurements including baseline. Concurrently we will examine implementation processes of
delivering MOTIVATE (Aim 2). Using semi-structured interviews, we will explore the contextual factors, barriers
and facilitators to implementation and uptake of MOTIVATE, among Veterans, frontline providers, health
coaches, and facility leaders (n~50). We will use the i-PARIHS implementation framework to inform the
discussion guide. Aim 3 will provide necessary cost evaluation of MOTIVATE along with budget impact
analysis from the perspective of a VA facility to estimate the costs of implementing MOTIVATE.
Implementation/Next Steps: Results will facilitate national implementation and dissemination of MOTIVATE,
along with a hybrid type 3 trial, which can augment the care provided by primary care, mental health, and
specialty services to improve outcomes in older Veterans with comorbid MSK pain and depressive symptoms.

Public health relevance
Narrative Chronic musculoskeletal (MSK) pain and co-occurring depressive symptoms often result in refractory disease, worse outcomes, and additional burden on the patient and society, costing over $600 billion annually. An accessible, safe, and effective behavioral intervention targeting older Veterans with chronic MSK pain and comorbid depressive symptoms is sorely needed, especially in older populations where the efficacy and safety of pharmacologic options are less favorable. We propose to conduct a hybrid type 1 randomized controlled trial at two large VA facilities to evaluate the effectiveness, implementation processes, and cost of MOTIVATE-- a health coach, virtually delivered, behavioral intervention for older Veterans with MSK pain and depressive symptoms. Results from this research will inform the scalability and implementation of MOTIVATE to ultimately improve pain interference, depressive symptoms, among other outcomes in a rapidly growing population of older Veterans with co-occurring MSK pain and depressive symptoms.